Improving Mental Health and Social Connectivity for Older Adults through Virtual Reality-Based Social Interventions

The United States is experiencing a public health crisis due to the prevalence of social isolation among aging
individuals, the lack of access to social and mental health tools, the dramatic increase in Alzheimer’s disease
(AD) and Alzheimer’s Disease and related dementias (ADRD), and the challenges associated with caregiving for
this population.1-3 Older adults living at home are sufficiently distinct from their counterparts in senior living in
socioeconomic diversity and access to enriching social networks,4 and face increased risks of social isolation
and the array of associated cognitive and mental health comorbidities, including depression and anxiety.5,6 The
virtual reality (VR) platform, Rendever, provides an innovative and clinically validated solution to these
challenges by enabling older adults to maintain important social family relationships, engage fully with life, and
reconnect with their past. The product’s approach enables members of senior living communities and others in
the community (e.g., older adults living at home) to engage together in enriching virtual environments through
its advanced communication and network capabilities. Our Phase I and II STTR projects have shown that the
technology is not only feasible for older adults with AD/ADRD, but it is safe, easy to use, highly satisfying, and
transformative for human relationships when people use it together.7,8 Until recently, Rendever has only been
available to residents of senior living communities and hospice and their family members. This
Commercialization Readiness Program proposal expands on our existing work to increase the viability of rapid
market adoption within senior living communities, and utilize our network of enterprise care partners to bring
Rendever into the home environment, where an estimated 90% of older adults prefer to stay throughout the
aging process.9 We seek to connect older adults aging in place at home with those living in senior living
communities, where Rendever is already used successfully, through shared VR experiences. To connect these
two groups, this project will (1) refine Rendever’s long-distance communication features and implementation
logistics for the individual home market, (2) conduct an initial commercial pilot of those features via two
distinct B2B2C routes, and (3) rigorously test the impact of Rendever’s at-home program on social, emotional,
and mental health outcomes for 250 home-dwelling older adults (MMSE 20 or higher) and their family
caregivers by partnering with a national home health care provider for a randomized clinical trial. By including
these populations, the project will evaluate Rendever’s impact on individuals most vulnerable to cognitive
decline and social isolation and gather data to support commercialization through home care providers.
Expanding Rendever into the home market can provide a new communication technology for millions facing
the functional challenges of aging, ADRD, and social isolation and provide a social infrastructure for
community building based on positive, shared experiences. This project will provide Rendever an
evidence-based solution to improve vitality, social and mental health, and quality of life.

Public health relevance
This Commercial Readiness Pilot project builds on the success of our Phase I pilot study and Phase II STTR clinical trial by extending Rendever's virtual reality (VR) platform to enhance social connectivity among older adults who are aging in place, a majority of the aging population that Rendever is not yet serving. Older adults living at home will be connected with those living in senior living communities, where Rendever is already successfully implemented, through shared VR experiences. This project contributes to public health by testing the expanded networking capabilities of Rendever on the social health, cognitive health, mental health, vitality, and quality of life of older adults who are aging in place with diverse cognitive abilities, with the goal of building a much needed infrastructure for social connectivity to combat the social isolation and cognitive and mental health challenges in this population, while also developing third-party reimbursement mechanisms that can broaden access to this promising technology.